Mapping gene expression in the developing mouse brain

DESCRIPTION (provided by applicant): Gene expression in the brain is important for understanding the genetic control of brain development. Because the laboratory mouse shares many genes and disease loci with human, its gene expression patterns are important for research in this area. With modern high throughput techniques, large scale gene expression data in the mouse brain are becoming available, and several mouse gene expression databases are being established. To integrate and analyze gene expression data with neuroanatomy in the embryonic and neonatal mouse brains, it is necessary to create three dimensional reference atlases of the developing mouse brain and tools that can map gene expression data into the atlas and perform analysis and visualization. The proposed study will establish a series of three dimensional reference atlases of the developing mouse brain based on high spatial resolution and rich tissue contrast provided by modern magnetic resonance imaging techniques. The atlases will contains structural annotation/segmentation, and more importantly, information on morphological changes during development obtained using advanced computational techniques. The proposed study will also develop tools that mapping gene expression data to the reference atlases. A selected group of gene expressions will be mapped, validated, and studied. The mapped gene expression data will also help us to define more detailed structures in the developing mouse brain atlases.

Public health relevance
PUBLIC HEALTH RELEVANCE: In this project, three dimensional atlases of the developing mouse brain will be developed to serve as the reference for mapping high resolution gene expression data. The atlases will consist of high resolution, rich contrast, and group average data that cover the key embryonic to neonatal stages during brain development. Techniques and software for mapping gene expression data to the atlases will also be developed, validated and used to investigate the relationship between gene expression and anatomical phenotypes as well as further enrich the structural annotation in the atlases. In this project, three dimensional atlases of the developing mouse brain will be developed to serve as the reference for mapping high resolution gene expression data. The atlases will consist of high resolution, rich contrast, and group average data that cover the key embryonic to neonatal stages during brain development. Techniques and software for mapping gene expression data to the atlases will also be developed, validated and used to investigate the relationship between gene expression and anatomical phenotypes as well as further enrich the structural annotation in the atlases. __SpecificAimsTextDelimiter__ Three-Dimensional Atlas Based Gene Expression Mapping in the Developing Mouse Brains 2. Specific Aims The laboratory mouse plays an essential role in the ongoing efforts to understand the genetic control of the organization, development, and disease process of the mammalian central nervous system (CNS). Gene expression interprets the genetic code and controls the CNS phenotype at the most fundamental level. Cells in different brain regions often exhibit unique spatial and temporal varying patterns of gene expression. This phenomenon is essential for us to understand the mechanism of genetic control, cell lineage and migration, and tissue differentiation. The large scale gene expression data herald the need to simultaneously map multiple gene expression data in the embryonic and postnatal mouse brains to comprehensively analyze gene expression patterns, cell type specificity, and their relationships with functional anatomy in the developing mouse brain. The goal of the proposed project is to establish an atlas based system that integrates gene expression data with murine neuroanatomy. The system will contain: 1) serial reference atlases of embryonic and neonatal mouse brains based on high resolution, high fidelity, rich contrast magnetic resonance (MR) images; 2) mapping techniques and software that ensure accurate and efficient integration of gene expression and MR data. The atlases will serve as templates for mapping and comparing gene expression patterns. They will also serve as foundations for analyzing gene expression data in the context of neuroanatomy, which include structure annotations and quantitative measurements of brain development. We will integrate these resources with the ongoing effort for comprehensive gene expression mapping directed by Dr. Blackshaw, which will lead to not only the advance in our understanding of brain development, but also enrich the mouse brain atlases developed in this grant. We have the following aims, with the first two aims focus on creating the system and the last two aims focus on applying the system to analyze gene expression data and correlate with functional anatomy. Aim 1: Establish reference mouse brain atlases based on high resolution, rich contrast MR images of the embryonic and neonatal mouse brains Our goal is to use the high resolution, rich contrast, three dimensional (3D) MR data to construct population averaged reference images and atlases from embryonic day 10 (E10) to postnatal day 7 (P7) with high temporal resolution (12 hour intervals for embryonic and 24 hour intervals for postnatal stages). Brain structures will be annotated and segmented based on the rich contrasts provided by MRI, and mappings between images at adjacent developmental stages will be generated to facilitate analysis of temporal gene expression data. This will collaborate with the ongoing mouse brain atlas project by Drs. Mori and Paxinos (EB003543) and we will share our resources as much as possible. Aim 2: Develop mapping techniques and software for comparing gene expression patterns in the reference brain atlases Our goal is to develop techniques and tools to accurately map in situ hybridization sections to the reference brain atlases in an automatic or semi-automatic fashion and to analyze and visualize gene expression data within the neuroanatomical framework. The accuracy of the tools will be examined. Both the atlases and software will be put on public domain. Aim 3: Mapping extensive gene expression data to the mouse brain atlases We will use the high spatial - temporal MRI atlases to map the extensive gene expression resources generated by Dr. Blackshaw's team. In the first period of this grant, we will map 20 genes that are important markers of the substructures in the brain or are crucial to brain development. The atlases will provide a 4D template to map multiple gene expressions and a platform to investigate their spatial and temporal patterns. Aim 4: Enrich the MR based reference brain atlases with neuroanatomical information provided by gene expression data. Many emerging (and sometimes transient) structures can only be assigned by gene expression data. The mapped gene expression data in Aim 3 will, therefore, allow us to identify and assign many MR-visible structures in the developing mouse brains. Our goal in this aim is to use the gene expression data to define more substructures in the atlases, which are not possible if based solely on MR contrasts. The additional neuronanatomical information will enrich our atlases and enhance the values of the reference resources.